STAFF PRIORITY TIME LOW RESOLUTION DIFFRACTION STUDIES OF VIRUS CRYSTALS

With the use of the low resolution single crystal diffraction setup, we were successful in measuring precisely the low angle diffraction spots of very low indexes from large unit-cell virus crystals. After the encouraging short trial run on the SSRL beam line 1-4, we were able to record the first low resolution data with the HK97 bacteriophage system at the BL4-2 SAXS/D facility. Further instrumental improvements later allowed us to obtain improved HK97 low resolution data and we also measured other plant virus systems. These studies were later expanded to a separate experimental proposal (J.E. Johnson et al.), and the most significant outcome of the preliminary studies is described in the 'highlight' section of this annual report.